Housing, Health, and Disability: The Role of Housing Assistance and Housing Insecurity among Older Adults of Low-Income

Project Summary: Housing insecurity is a pressing public health problem: U.S. rates are the fastest-growing
among older adults, one-third of whom spend more than 30% or 50% of their income on housing. Housing
insecurity―defined as limited access to and availability of affordable, stable, safe, and adequate housing and
neighborhoods― is a risk factor for numerous adverse health outcomes including chronic conditions, disability,
and mortality. Although federal housing assistance is associated with improved health outcomes, current
programs support only about one-third of income-eligible, cost-burdened adults aged 50+ who need
assistance. Moreover, the relationship between housing assistance, housing insecurity, and adults' health and
disability trajectories remains poorly understood. One unexplored area is how housing assistance and multiple
dimensions of housing insecurity experienced during emerging adulthood, a critical life course period, relate to
midlife and older adult health and disability trajectories. While previous research has examined effects of
housing assistance and housing insecurity on health, studies often use cross-sectional or convenience
samples, focus on a single rather than combined effects of multiple housing insecurity dimensions, and rarely
include income-eligible older adults who do and do not receive housing assistance. Examining how previous
housing histories relate to health and disability later in life will enhance our understanding of when housing
assistance and housing insecurity matter most, and inform future housing interventions. The proposed K01
study leverages more than 50 years of nationally representative, prospectively-collected longitudinal life course
data from the Panel Study of Income Dynamics to examine how midlife and older adult health and disability
trajectories relate to housing assistance and housing insecurity experienced during emerging adulthood, a
critical life course period. This project seeks to: (1) develop typologies of housing assistance and housing
insecurity life course histories for midlife and older adults; (2) examine how trajectories of health and disability
during midlife and older adulthood relate to previous histories of housing assistance and housing insecurity;
and (3) assess the extent to which relationships between midlife and older adult health and disability
trajectories and housing history typologies vary by neighborhood context. Complementing this research, a
detailed training plan will build on the applicant's prior training in environmental psychology and architecture to
include (1) aging, gerontology, and life course theory; (2) age-related disability, mobility, and physical function;
(3) longitudinal survey data analysis skills, including latent variable modeling; and (4) external grant-writing
skills. This integrated training will prepare the applicant for a successful independent research career focused
on aging, housing, and neighborhoods. Findings from this proposal will generate critical insights concerning for
whom, how, and when housing assistance and housing insecurity matter most for midlife and older adults'
health and disability, inform future housing interventions, and elevate older adults' need for housing assistance.

Public health relevance
Project Narrative Housing insecurity is a pressing public health problem that affects one-third of U.S. older adults. The goal of this proposal is to identify how housing assistance and housing insecurity experiences during adulthood shape health and disability trajectories among midlife and older adults, especially those with low incomes. Study findings will generate critical insights concerning for whom, how, and when housing assistance and housing insecurity matter most for older adults' health and disability and inform future housing assistance programs and interventions to enhance health, lengthen life, and reduce illness and disability.